Investigating and Utilizing Microbial Appendages

Project Summary
This research program seeks to understand the fundamental mechanisms underlying the production,
regulation, and function of microbial appendages, such as flagella and pili, and to use this knowledge to design
self-assembled nanofibers for various biochemical applications. Microbial appendages, including flagella and
pili, are essential structures that prokaryotic cells invest significant energy in producing. These appendages
extend microns from the cell surface and play crucial roles in bacterial survival, adaptation, and virulence. Our
recent work has focused on elucidating the structural and functional diversity of flagellar outer domains,
revealing their roles in diverse functions such as surface attachment, colonization, and biofilm formation. We
have also discovered new types of appendages, such as the extracellular cytochrome nanowires in both
bacteria and archaea, which expands our understanding of microbial electron transfer mechanisms.
Additionally, we have made progress in understanding the dynamics of pili production, demonstrating how a
single pilin subunit can assemble into distinct pilus structures under different conditions, highlighting the
adaptability of these structures. In the next five years, we plan to investigate several key areas that align with
the overall vision of this project. One focus will be to uncover the interaction between the membranous sheath
and a particular class of flagella outer domains in H. pylori. Understanding this interaction could lead to novel
strategies for disrupting bacterial colonization and reducing the risk of severe complications. We also aim to
discover and characterize a new class of pili in cyanobacteria, exploring their role in colony formation, toxin
interactions, etc. Finally, we will combine our knowledge of cytochrome nanowires with self-assembled
peptides to design self-assembled conductive nanowires. Our research program has the potential to
significantly advance our understanding of microbial appendages and their roles in bacterial physiology and
pathogenesis. Furthermore, the development of self-assembled peptide nanofibers could lead to innovative
biomaterials with broad applications in biomedicine, opening new avenues for treatment and technological
advancement.

Public health relevance
Project Narrative This research proposal aims to investigate the intricate interplay between the membranous sheath and flagella in H. pylori, seeking to uncover the role of flagellar outer domains in bacterial virulence. Additionally, we will embark on the discovery and characterization of a new class of pili in cyanobacteria, exploring their contribution to colony formation and toxin interactions, with implications for understanding and mitigating harmful algal blooms. Finally, by using cutting-edge protein design tools and our previous discovery in cytochrome nanowires, we will design self-assembled conductive nanowires, a new class of biomaterials that may be used in many future biomedical applications.